Leveraging Myelin-Sensitive Imaging to Predict Early Lesion Pathogenesis in Cerebral Adrenoleukodystrophy

ABSTRACT
X-linked Adrenoleukodystrophy (ALD) is a devastating neurological disorder caused by mutations in the
ABCD1 gene. The estimated incidence of disease is 1/17,000, however the recent institution of newborn
screening has revealed significantly higher rates. The majority of patients will develop cerebral ALD (CALD),
with the highest incidence occurring in childhood. Most patients undergo inflammatory demyelination followed
by neurodegeneration and death in 2 to 3 years. Hematopoietic Stem Cell Transplant (HSCT) is most effective
when initiated in the narrow window prior to the onset of neurological symptoms. There is an explicitly stated
need for more sensitive measures to detect lesion onset and progression. Early diagnosis of CALD will widen
the treatment window, provide lead-time for possible preventative strategies, and thereby help maximize
neurological outcomes. Decreased overall lipid content, increase in myelin very long chain fatty acid lipid
fractions, and decrease in myelin water content are the earliest pathological changes in CALD, prior to
demyelination. Diffusion Tensor (DTI) and Myelin Water Fraction (MWF) Imaging are advanced, in vivo
modalities specific to local fiber architecture and myelin water content. Dr. Mallack hypothesizes that
abnormal microstructural changes in early CALD during myelin development can be detected by DTI
and MWF prior to the onset and/or progression of demyelination. Dr. Mallack will test this hypothesis by
investigating individual white matter tract development (Aim 1), and lesion onset and progression (Aim 2), in
pediatric patients who developed CALD, asymptomatic hemizygotes, and controls. If his hypotheses are
validated by this study, the approach will (1) confirm normal myelin development in patients with CALD, (2)
reframe early CALD as a regional, tract-specific, divergence from the expected white matter tract maturational
curve, (3) provide a sensitive modality for early disease monitoring, and (4) aid in prediction of patients
appropriate for therapy.
By achieving these aims, Dr. Mallack will undergo rich inter-institutional mentorship by Dr. Florian Eichler, a
world expert in the leukodystrophies, at Massachusetts General Hospital and Dr. Sumit Niogi, a leader in
advanced neuroimaging, at Weill Cornell Medical College. Additionally, Dr. Mallack will be guided by a team
with complementary expertise in neurogenetic disorders, advanced imaging biomarker development and
investigation, and biostatistics. In addition to his career development activities, Dr. Mallack's committee of
mentors, collaborators, and advisors will promote his development and transition to an independent
investigator. This will address his goals of (1) using advanced imaging techniques to probe the underlying
biology of genetic white matter disease, and (2) translate cutting-edge image analyses into clinical applications,
thereby advancing the care of patients affected by these devastating disorders.

Public health relevance
PROJECT NARRATIVE Cerebral Adrenoleukodystrophy (CALD) is a neurologically devastating, inflammatory demyelinating disease of childhood that leads to a vegetative state or death in months to years. Treatments are most effective when initiated in the narrow window prior to the onset of neurological symptoms, however early identification of CALD is a significant challenge. In this project, we will study the transition from normal brain development to cerebral demyelination using advanced imaging techniques in order to widen the treatment window, provide lead-time for possible preventative strategies, and thereby help maximize neurological outcomes.